A software tool to facilitate variable-level equivalency and harmonization in research data: Leveraging the NIH Common Data Elements Repository to link concepts and measures in an open format

Abstract
The National Institute on Aging (NIA) supports numerous studies and archives that collect and disseminate
critical data about the aging population of the United States. By supporting the collection and dissemination of
longitudinal and multidisciplinary data, the NIA provides researchers the opportunity to measure change and
stability in individuals over time, as well as to investigate aging phenomena from an integrated theoretical
perspective. In both cases, equivalent or related variables must first be linked or merged before producing
appropriately documented data products for eventual harmonization and analysis. The current aging research
data environment provides many opportunities for linking similar topical datasets and harmonizing extant
common variables, but few software tools are available to facilitate this resource-intensive task. The proposed
project will demonstrate the feasibility of a guided harmonization software prototype by concording variables
from three nationally representative NIA-funded studies (MIDUS, NHATS, NSHAP) and mapping them against
extant data element concept sources such as the NIH Common Data Elements library to identify equivalent
concepts and variables. The software prototype will use machine learning and advanced text analysis
algorithms to guide the creation of concorded databases (variable crosswalks) that support harmonization and
discoverability, both within and across aging-related statistical datasets.
Additionally, the prototype will use an open-standards metadata framework to produce richly-described
concordance databases that are interoperable, citable and FAIR. Colectica has a track record of creating open-
standards based software tools that reduce data management burden by automatically extracting structured
metadata from macro-level (study) and micro-level (variable) characteristics of aging studies. Specifically, the
prototype will evaluate the feasibility of human-in-the-loop algorithms to operate as a “recommendation engine”
to guide the concordance of potentially equivalent or similar variables among multiple datasets. The core
hypothesis posits that the prototype will significantly decrease the labor, time, and resources required to create
accurate and standardized concorded databases. To test this hypothesis, the research team will: construct and
evaluate recommendation algorithms for variable concordance (Aim 1); establish metrics for measuring the
accuracy and effectiveness of concordance (Aim 2); and create a user interface to test the recommendation
engine, its functions, and associated inputs and outputs (Aim 3).

Public health relevance
Relevance to Public Health The current research data environment provides many opportunities for linking similar topical datasets and harmonizing extant common variables, but few software tools are available to facilitate this resource-intensive task. This project proposes using an open-standards framework to assemble richly-described datasets that are mapped against the NIH Common Data Elements (CDE) library to identify equivalent concepts and variables. Machine learning will guide data managers through this process and produce variable crosswalks that can aid harmonization and discoverability both within and across studies and datasets.